Long Non-coding RNAs in Adipogenesis

DESCRIPTION (provided by applicant): The mammalian genomes express a large number of long noncoding RNAs (lncRNAs). Only a handful of them, however, have been studied. The known lncRNAs have diverse roles in the cell, mostly in the nucleus, such as chromatin remodeling, transcription, and RNA processing. Adipogenesis is the process that generates adipocytes from precursor cells, which have many implications for human diseases, such as diabetes and cardiovascular diseases. While regulation of protein-coding genes in adipogenesis has been well studied, the role of lncRNAs is completely unclear. We have sequenced the transcriptomes of human and mouse cells undergoing adipogenesis to an unprecedented depth. Our preliminary analysis indicates that a set of lncRNAs are highly regulated during adipogenesis, suggesting their functional roles in the process. In this grant, we plan to examine known and novel lncRNAs that are regulated in adipogenesis for their roles in differentiation of precursor cells into mature adipocytes. PUBLIC HEALTH RELEVANCE: Adipocytes have many implications for human diseases. Aberration in fat cell number leads to obesity, which is rapidly becoming a serious public health problem around the world, and is related to other common diseases, such as type II diabetes and cardiovascular diseases. Adipogenesis is the process that generates adipocytes from precursor cells, which involves a cascade of signaling events leading to regulation of genes that play roles in cell proliferation and differentiation. In this grant, we will identify and examine long noncoding RNAs (lncRNAs), which are increasingly found to be associated with various key functions in the cell. However, their roles in adipogenesis are completely unclear.

Public health relevance
Adipocytes have many implications for human diseases. Aberration in fat cell number leads to obesity, which is rapidly becoming a serious public health problem around the world, and is related to other common diseases, such as type II diabetes and cardiovascular diseases. Adipogenesis is the process that generates adipocytes from precursor cells, which involves a cascade of signaling events leading to regulation of genes that play roles in cell proliferation and differentiation. In this grant, we will identify and examine long noncoding RNAs (lncRNAs), which are increasingly found to be associated with various key functions in the cell. However, their roles in adipogenesis are completely unclear.